Feasibility of large-scale oocyte cryobanking of C57BL/6N mice and the influence of donor microbiome on recovery and genomic stability

Project Summary
The goal of this project is to establish large-scale oocyte cryopreserve and assess the viability,
cost and animal savings, as well as determine what factors may influence the recovery of viable
rederived mice. Our experience in cryopreservation has shown varying quality of recovered
oocytes among different vendors, even within a specific mouse strain. We will cryopreserve
oocytes from C57BL/6N mice from the four most commonly used vendors (Jackson, Charles
River, Taconic and Envigo). We compare the quality of oocytes through IVF to the blastocyst
stage as well as to live birth. We will also examine possible corollaries to embryo quality including
genome aneuploidy and the microbiome of the donor dams. This data will inform our
implementation of large-scale preservation and rederivation and identify factors that influence
successful outcomes. This proposal will lead to efficiencies in cryopreservation of haploid
gametes (oocytes) and success would; i) reduce costs related animal shipments required on
demand of a project ii) would eliminate the requirement to synchronize oocyte production and ET
recipient mice’s estrus cycle, iii) enable testing of each batch of oocytes for developmental
competency, iv) improve successful live pup production rates and reduce the time between when
a researcher orders an IVF recovery and we can provide animals, v) and collectively, the use of
cryopreserved oocytes will reduce the operating expenses of MMRRC. This information will be
shared with the other three MMRRCs either during our monthly consortium meetings or during
our annual consortium meeting. Additionally, this information will be shared widely through
publications and presentations.

Public health relevance
PROJECT NARRATIVE The Mutant Mouse Resource and Research Center at the University of Missouri (MU-MMRRC) develops tools to optimize and facilitate research using mouse models of disease. These include studies that evaluate methods of cryopreservation and recovery of germplasm. This proposal’s goal is to establish oocyte cryopreservation to facilitate the rapid resuscitation of cryopreserved GEM mouse models and reduce costs through the identification of factors that influence recovery rates including genomic aneuploidy and influences of the microbiome on oocyte quality.